Path B CDFA Continuation and Enhancement of the Produce Safety Program

California Department of Food and Agriculture
PAR-21-174
Project Period: 2021-2026
Project Summary/Abstract
The request in this proposal allows the California Department of Food and Agriculture (CDFA) to
continue the development of a sustainable Produce Safety Program within California. This will be
accomplished by enhancing the current program to conduct the necessary farm inspections; provide
education, outreach, and technical assistance to growers; and develop a farm inventory database.
CDFA chose to respond using Path B and will complete all applicable program objectives:
• Goal 1: Conduct ongoing program assessments and planning while maintaining foundational
resources that are essential to sustainable implementation of the PSP.
• Goal 2: Routinely provide education, outreach, and technical assistance opportunities.
• Goal 3: Establish a robust farm inventory within a database management system to maintain a
complete and accurate database of California produce farms.
• Goal 4: Create an integrated inspectional approach that represents and enables a proactive
(partnership) approach to foodborne outbreaks and focusing on education of growers.
• Goal 5: Implement the compliance and enforcement program with emphasis on consistency.
• Goal 6: Strengthen CDFA’s event response planning infrastructure to build upon existing
systems for detecting, investigating, analyzing, and mitigating foodborne illness outbreaks.
To achieve these goals, CDFA will continually assess and strategically plan to increase the capacity of
the existing regulatory program; perform ongoing expansion and quality control of the produce farm
inventory; provide opportunities for education and training using evidence-based, nationally consistent
training and workshops; and utilize a systems approach to maintain and further develop a
comprehensive compliance and enforcement program focused on quality and national consistency.
Expected Outcomes: Continued development of the PSP will reduce public health risks for
consumers of California produce across the nation. Utilizing a systems approach including both
education and enforcement to promote understanding of and compliance with the PSR, CDFA will
encourage the safe growing/harvesting/packing/holding of fruits and vegetables, significantly advance a
national integrated food safety system, and effectively fulfill the requirements of FSMA.

Public health relevance
California Department of Food and Agriculture PAR-21-174 Project Period: 2021-2026 Project Narrative The main goal of the proposed project is to further develop, enhance, and sustain the California Food Safety Program to full conformance with the U.S. Food and Drug Administration’s (FDA) Food Safety Modernization Act, Standards for the Growing, Harvesting, Packing, & Holding of Produce for Human Consumption (Produce Safety Rule) through short and long-term interagency collaborations; and continued extensive cooperation and coordination with the FDA, other state and local agencies, and industry. These activities are intended to further enhance the State’s Produce Safety Program and its ability to reduce, prevent, and respond to food emergencies and better align it with a national integrated food safety system. Achieving the goal will better protect and improve the health of the public by assuring that food is produced safely and unadulterated.